Metabolic Tissue Function

ABSTRACT: Metabolic Tissue Function Core
The purpose of the Metabolic Tissue Function Core is to improve the efficiency of diabetes-related research
through provision of expertise, equipment, and services that optimize the investigational capacity of Diabetes
Research Center (DRC) members. The Core facilitates acquisition of high quality rodent and human islets and
assists investigators in developing induced pluripotent stem cells. In addition, the Core provides services for
the functional analyses of islets and other metabolic tissues relevant to the pathogenesis of diabetes and its
complications. These functional studies include hormone secretion assays, assessment of β-cell mass,
quantification of metabolism, and assessment of endoplasmic reticulum stress and oxidative stress pathways.
The expertise and state-of-the-art equipment provided by the Core improve the efficiency of research focused
on improving the diagnosis, treatment and cure of diabetes.

Public health relevance
PROJECT NARRATIVE: Metabolic Tissue Function Core The Metabolic Tissue Function Core provides expertise, services, and specialized equipment required for the study of pancreatic islets and other metabolic tissues. The Core thus assists DRC investigators in the pursuit of insights into the etiology and consequences of diabetes, information critical for developing new treatments for diabetes.